Validation of a Genomic Biomarker of Response to Environmental Tobacco Smoke

DESCRIPTION (provided by applicant): Second-hand tobacco-smoke (SHS) has a profoundly negative impact on the health of exposed individuals. In adults, where the long-term impacts of SHS exposure are more apparent, SHS is responsible for 50,000 deaths annually. In children, the effects of SHS are likely even more profound. Children exposed to SHS have median nicotine metabolite levels twice those of adults, and SHS exposure is a substantial source of childhood morbidity;resulting in lower respiratory illnesses;cough, phlegm, wheeze, and breathlessness;middle ear disease;and a lower level of lung function. A critical need in the area of research into the health consequences of SHS is the development of effective tools for assessing the early biological response to SHS. These tools could facilitate rapid insights into the causes and consequences of differences in the response to SHS exposure;and, unlike direct measures of SHS exposure levels, could also be used to assess the likely long-term health effects of interventions to minimize SHS exposure in both children and adults. Using genome-wide microarray technologies for assessing mRNA and miRNA expression together with the concept that tobacco smoke creates an airway-wide field of epithelial cell injury, we have developed innovative genomic biomarkers to assess the biologic response to SHS by profiling cells that can be collected from the mouth or nose using minimally invasive procedures. These biomarkers combine the expression levels of multiple genes or miRNAs into composite measures of tobacco-smoke exposure thereby amplifying the tobacco-smoke signal while dampening the otherwise noisy expression levels of individual genes. Preliminary studies show that expression biomarkers measured in buccal or nasal epithelium distinguish young adults with SHS exposure from unexposed individuals. The studies proposed here will validate these biomarkers for assessing the biological response to SHS in 80 SHS-exposed and 80 unexposed children participating in the CCCEH, DISCOVER and ASTHMA-DIET cohorts. Biomarkers of tobacco-smoke exposure derived from microarray-based measurements of nasal or buccal epithelial mRNA or miRNA expression will be compared to measures of SHS exposure derived from questionnaire, air sampling and cotinine. The repeatability of the genomic biomarker measurements will be assessed by repeat sampling of 40 children after 6 months. The proposed research applies innovative tools for measuring the biological response to SHS exposure to multiple established cohorts with carefully characterized exposures, including children at risk for SHS-related disease. The studies bring together a team with expertise in pulmonary medicine, epidemiology, genomics, and biostatistics, a long-term interest in understanding responses to tobacco smoke, and an established record of effective collaboration, to take a critical step in establishing the potential and feasibility of applying these SHS-exposure assessment tools to large-scale epidemiology and gene-environment studies. By measuring the response to exposure, rather than the exposure itself, these studies have the potential to broadly change the paradigm for research into the effects of environmental exposures. PUBLIC HEALTH RELEVANCE: Narrative Over 100 million people living in the U.S. are exposed to second-hand tobacco-smoke (SHS) which is responsible for 50,000 U.S. deaths annually, has a profoundly negative impact on health, and disproportionately affects children, especially the urban poor. This project seeks to validate novel biomarkers for assessing the body's response to SHS exposure that can be measured in large population studies of the health effects of SHS. By measuring the response to exposure, rather than the exposure itself, these tools will allow insights into how individuals respond differently to SHS exposure, the relationship between this response and the risk of disease, and provide a unique tool for evaluating the effects of SHS exposure minimization efforts on the physiologic burden that results from exposure to this deadly environmental pollutant.

Public health relevance
Narrative Over 100 million people living in the U.S. are exposed to second-hand tobacco-smoke (SHS) which is responsible for 50,000 U.S. deaths annually, has a profoundly negative impact on health, and disproportionately affects children, especially the urban poor. This project seeks to validate novel biomarkers for assessing the body's response to SHS exposure that can be measured in large population studies of the health effects of SHS. By measuring the response to exposure, rather than the exposure itself, these tools will allow insights into how individuals respond differently to SHS exposure, the relationship between this response and the risk of disease, and provide a unique tool for evaluating the effects of SHS exposure minimization efforts on the physiologic burden that results from exposure to this deadly environmental pollutant.